SUPPORT SERVICES FOR THE PLCO ETIOLOGIC&EARLY MARKER STUDIES (PLCO EEMS)

This contract provides services that support all aspects of the Prostate, Lung, Colorectal and Ovarian (PLCO) cancer screening trial’s Etiologic and Early Markers (EEMS) program administration, including systems administration, web hosting, peer review logistics and tracking, sample requisition, progress monitoring of the approved studies, and other related tasks . The PLCO EEMS program encompasses all research projects that involve the use of the PLCO samples (and to a limited extent, the National Lung Screen Trial samples).